Primary-care strategies to enhance weight management after discontinuation of anti-obesity medications

PROJECT SUMMARY
The use of anti-obesity medications (AOMs) is rapidly increasing, driven by the approval of newer incretin-
based treatments, including both GLP-1 receptor agonists and combination GLP-1/GIP receptor agonists.
Despite their efficacy, discontinuation rates for these medications are high, and stopping treatment often leads
to rapid and significant weight regain. Intervening with behavioral intervention after AOM discontinuation may
reduce the steep regain curve. However, it is currently unclear how to engage with these patients quickly to
improve long-term weight management and health benefits. Primary care clinics are essential settings for
intervention after AOM discontinuation because primary care providers frequently treat obesity and prescribe
AOMs. Unfortunately, there is little evidence to suggest that patients receiving obesity treatment in primary
care settings have access to behavioral support to accompany AOMs discontinuation. The long-term goal of
this research is to develop a weight management treatment program for individuals discontinuing AOMs that
can be widely implemented in primary care. In this feasibility project, we will leverage the EHR and a low-
burden self-reporting method to track the natural progression of AOM use and discontinuation in primary care
patients prescribed AOMs. We will use this system as the foundation of a primary care-based program that
quickly identifies patients who discontinue their medication and enrolls them into a behavioral weight
management program. The behavioral weight management program being evaluated in this project is
specifically designed to enhance weight management following discontinuation of AOMs. A unique component
of the program is its emphasis on reducing food cue reactivity, a specific issue of concern for those
discontinuing AOMs. The program will be a self-tailored, automated program paired with remote patient
monitoring of weight change. In response to PAS-23-086, this program will be evaluated in a 6-month, two-arm
feasibility study (N = 90) compared to a usual care arm. Outcomes of interest will be 1) feasibility of
recruitment, 2) acceptability of the program, and 3) documenting the efficiency of study processes. We will
conduct key informant interviews with providers and clinic staff to guide future implementation efforts. The
completion of the study will provide strong preliminary data for a future application that will propose a fully
powered, hybrid trial (type 1) evaluating the efficacy and initial implementation strategies of this comprehensive
primary care-based obesity management program. This line of research has the potential to offer pivotal
insights into best practices for long-term weight management after AOM discontinuation and bridge the gap
between pharmacological and behavioral strategies for obesity management in primary care.

Public health relevance
PROJECT NARRATIVE Anti-obesity medications (AOMs) are increasingly prescribed and managed in primary care practices, but most patients discontinue treatment in less than a year. This project aims to characterize the context of AOM discontinuation in primary care settings and evaluate the feasibility of implementing a system to track and engage patients in a behavioral weight management program after AOM discontinuation. The project will provide pivotal insights into best practices for long-term weight management incorporating AOMs in primary care settings.